Support your Heart: Feasibility trial of a cardiovascular health intervention for young adults

Cardiovascular disease (CVD) is a major health problem in the US, affecting nearly 50% of adults. While CVD
prevalence has remained stable over the last two decades, acute cardiac events have increased in young
adults. The prevalence of CVD increases with age making early intervention and prevention essential. Seven
of every 10 cases of CVD could be prevented by managing lifestyle factors. The American Heart Association
(AHA) introduced cardiovascular health metrics (i.e., Life’s Essential 8 [LE8]: sleep, physical activity, blood
glucose, blood lipids, blood pressure, smoking, body mass index, and diet), reflecting a shift towards health
promotion and preservation throughout the life course versus disease treatment. Only 27% of young adults
meet the threshold for ideal cardiovascular health. What remains missing from the AHA’s metrics is a focus on
psychosocial factors that are associated with adverse cardiovascular outcomes, such as social isolation,
loneliness and stress. Further, the US Surgeon General identified an urgent public health need to address the
“epidemic of loneliness and isolation” particularly among young people. Currently, there are no intervention
studies that seek to address the impact of social isolation and/or loneliness on cardiovascular health among
young adults. Our research team has experience developing and delivering telephone coping skills
interventions for patients with advanced lung disease, and tailored interventions for health risk behaviors. In
the current proposal, we will apply these precision prevention approaches to a health coach delivered
intervention for young adults targeting the AHA’s LE8 indicators, and collect data regarding the intervention
feasibility and acceptability. This R34 will consist of a development phase which will include co-development of
the Support Your Heart telephone intervention and a pre-pilot single arm 12-week study (n=20). To minimize
costs and maximize acceptability, Support Your Heart will include access to the current standard of practice
from the American Heart Association to address LE8 (the MyLifeCheck© App). Feasibility metrics will include
acceptability, satisfaction, adherence and retention. Following the development and pre-pilot testing, we will
conduct a pilot randomized feasibility trial (n=50) comparing Support Your Heart to MyLifeCheck© in a 6-month
randomized controlled pilot trial. Results from this pilot feasibility trial will provide preliminary evidence to
support a fully powered randomized controlled trial examining whether Support Your Heart improves LE8 over
a 1-year period compared to standard American Heart Association materials. Support Your Heart using health
coach delivery is significant because it addresses cardiovascular health among young adults using a precision
public health approach and covers stress, social isolation, and loneliness. With this integration we take a
strengths-based approach, which is consistent with the American Heart Association’s shifting emphasis on
primordial prevention. This research has the potential for substantial public health impact by addressing both
cardiovascular health, social isolation, loneliness and stress which comprise significant health burden.

Public health relevance
This project will contribute to the understanding about how to best address cardiovascular health and social isolation, stress and loneliness among young adults. It is expected that this program will establish the feasibility and acceptability of the Support Your Heart intervention, a health-coach delivered program for young adults with suboptimal cardiovascular health. If initial efficacy of the intervention is supported as anticipated, young adults will have a valuable asset to assist them with their cardiovascular health and social relationships which are important for lifelong health.